Southern Environmental Health Study

SUMMARY
Approximately 80% of human cancers are caused by adverse environmental exposures,
unhealthy lifestyles and/or their interactions with host susceptibility factors. Previous studies have
mostly focused on evaluating behavioral risk factors, such as tobacco smoking, physical inactivity,
unhealthy diets and obesity. While more than 80,000 chemicals have been registered by the EPA, very
few of them have been adequately investigated in relation to human cancers in epidemiologic studies.
There are considerable challenges in studying environmental exposures in epidemiologic studies.
Humans are exposed to large numbers of chemical and physical substances and their mixtures,
typically at low levels over extended periods of time. Previous environmental epidemiologic studies
have mostly evaluated exposures one at a time. However, because of a typically weak association of a
given exposure with disease risk, coupled with limited tools and biomarkers for environmental
assessments, most studies have failed to provide convincing evidence to link environmental exposures
to cancer risk. To overcome these challenges, we propose to establish a large cohort study including
~50,000 participants with an extensive collection of survey and geospatial exposure data, as well as
biological and environmental samples, to address critical issues in the environmental etiology of cancer.
Utilizing a framework of community-engagement to help inform research, enhance recruitment and
retention efforts, and disseminate results, we will focus on recruiting low-income and minority
populations who are more likely to live in resource deprived and heavily polluted communities. We
propose to include 1,500 of the study participants in a deep-exposome study to comprehensively
assess the exposome, identify key biomarkers of external exposures, examine associations of external
and internal metrics with cancer-related biological responses, and develop cumulative exposome risk
scores. The proposed study will enable direct evaluation of associations of environmental exposures
with cancer outcomes in the long term, and associations with cancer intermediate biomarkers in the
short term. By integrating environmental exposure data from multiple sources, including personal
exposure assessments and biologic markers of environmental exposure and responses, this proposed
study will allow us to systematically and rigorously investigate environmental exposures in relation to
cancer risk and provide substantial novel data to improve the understanding of both external and
internal exposomes, which will pave the way for future remediation of environmentally induced cancer.

Public health relevance
NARRATIVE Humans are exposed to large numbers of physical and chemical substances. However, it is unclear what exposures may increase the risk of cancers. Herein, we propose a research program to address critical issues in environmental epidemiology of cancer and establish a large cohort study in low-income and minority populations to systematically investigate environmental exposures for cancer risk.